Treatment of chronic venous thrombosis with histotripsy and thrombolytics

Summary: Deep vein thrombosis (DVT) is a major public health problem that affects 640,000 Americans each
year, and accrues $10B in healthcare costs. For critical thromboses, the American Heart Association and
Society for Interventional Radiology recommend thrombolytic drugs be administered to break down the
thrombus and restore flow in the vessel. Thrombolytic drugs are not effective for the 43% of DVT cases with
chronic thrombus, resulting in poor clinical outcomes for these patients. Adjuvant strategies are therefore
needed to ensure effective treatments for the entire thrombus. The scientific premise of this renewal project
is combining thrombolytic drugs with histotripsy, an ultrasound therapy that ablates tissue with the mechanical
action of bubble clouds, will improve outcomes for DVT patients. In the prior period of this project, we
established this combination treatment (histotripsy+) addresses all thrombus components, and resulted in
better outcomes than either approach individually in vitro and in vivo. In contrast, only a subset of thrombus
components could be treated with histotripsy or thrombolytic alone, which increases the likelihood for vascular
re-occlusion. These lessons have informed our revised approach in this Renewal Project, with an objective to
address current gaps that limit clinical deployment of histotripsy+.
In Aim 1, we will upgrade our histotripsy+ instrumentation. A phased source will be produced that generates
bubble activity along a 1 cm length of thrombus for single transmitted pulses, and enables treatment for up to a
5 cm segment with electronic steering. Bubble activity will be monitored volumetrically with a coaxial matrix
imaging probe using our passive and active imaging algorithms. We will adjust transmitted pulses in real time
to account for defocusing from tissue heterogeneity using the send/receive capabilities of the phased,
cylindrical transducer. Finally, treatment protocols and imaging markers will be established that ensure
effective outcomes based on time-resolved measurements of in vitro clot degradation, and confirmed with ex
vivo chronic human specimen. Studies in Aim 2 will assess the safety of histotripsy+ for DVT. Mechanisms of
platelet activation during histotripsy+ will be assess in vitro, and effective antithrombotic strategies to counter
will be determined in vivo. For chronically thrombosed veins that have a reduced compliance to strain, we will
identify exposure conditions that effectively treat chronic DVT but avoid vascular rupture in vivo. Additionally,
we will assess treatment-related changes to cellular composition of treated veins with our microfluidics-based
scRNA-Seq technique. Finally, studies in Aim 3 will gauge the influence of thrombus age (0 to 30 days) on
treatment outcomes of histotripsy+ to develop personalized treatment strategies based on stage of disease.
Following successful completion of the proposed studies, we will have produced a validated system for rapid
treatment of DVT, with sufficient data to confirm the safety and efficacy needed for clinical testing. Further, new
information will be gathered to address currently intractable venous thrombi.

Public health relevance
Project Narrative: Adjuvant strategies to thrombolytic therapy are needed for the 275,000 patients that develop chronic deep vein thrombosis each year. In this renewal project, we will extend our work that combines image-guided histotripsy with thrombolytic drugs to engineer new instrumentation for customizable treatment zones based on the target pathology, address safety concerns, and develop personalized treatment schemes that counter changes in the composition of thrombus with age. Successful completion of these tasks will enable us to bridge the current gaps that limit deployment of histotripsy as an adjuvant to thrombolytic therapy into the clinic.